Longitudinal Studies for Age-Associated Conditions in Sardinia Population Cohort

Provide service for the SardiNIA3 project which extends the studies of aging-associated conditions in the especially favorable Sardinian population with longitudinal assays of traits. Mod 1 Purpose: Store blood and urine samples and have samples shipped by request instead of using a schedule.